Home blood pressure and falls among older adults

Cardiovascular disease (CVD) is the leading cause of death among older US adults. Over 75% of US adults ≥
65 years of age have hypertension, a major risk factor for CVD. Randomized controlled trials have
demonstrated that lowering blood pressure (BP) through antihypertensive medication reduces the risk for CVD
by 20% to 40% among older adults with hypertension. Many older US adults have uncontrolled BP and may
receive CVD risk reduction benefits from intensifying their antihypertensive medication. However, clinicians
are often concerned that intensively lowering BP may increase the risk for a fall. Falls are the leading cause of
injury-related hospitalization and death among older US adults and more than one in three US adults ≥ 65
years of age experience a fall each year. BP has traditionally been measured in the clinic setting and a major
challenge that clinicians encounter in deciding to titrate antihypertensive medication is the inaccuracy of BP
assessed in this setting. Home blood pressure monitoring (HBPM) is an inexpensive and highly feasible
approach to measure BP outside of the clinic setting and has the potential to improve BP control and,
therefore, reduce CVD risk. Whether HBPM can identify patients for whom antihypertensive medication can be
intensified without increasing the risk for a fall is unknown. A newly NIH-funded (July 1, 2018 to June 30, 2022)
prospective cohort study (AMBulatoRy blOod preSsure In older Adults [AMBROSIA]) will evaluate the
association of BP, measured outside of the clinic setting using ambulatory blood pressure monitoring (ABPM),
with falls risk among 1,057 adults aged ≥ 65 years, taking antihypertensive medication from the Kaiser
Permanente Southern California (KPSC) health system. ABPM was chosen for the AMBROSIA study as it is
considered the gold-standard approach for assessing out-of-clinic BP. Compared to ABPM, HBPM is more
widely available in the US and better tolerated by patients. The AMBROSIA study is not funded to perform
HBPM. The overall goal of the proposed ancillary study to AMBROSIA is to determine whether BP on HBPM
can identify older adults taking antihypertensive medication who are at increased risk for falls, and whether
HBPM provides similar predictive value for falls when compared with ABPM. AMBROSIA will begin study visits
in February 2019 and the proposed ancillary study (AMBROSIA-HOME) will add the conduct of HBPM for 7
days, with two BP measurements obtained in the morning and two BP measurements obtained in the evening
on each day, following the conduct of ABPM for 1,000 participants. Conducting the AMBROSIA-HOME study
will be cost-efficient as information on demographic and clinical characteristics, geriatric assessments,
research-grade BP measurements, and 24-hour ABPM is already being collected at baseline with falls and
serious fall injuries being assessed during a one-year follow-up period. The AMBROSIA-HOME study will
provide valuable data on the role of HBPM to personalize care for older adults taking antihypertensive
medication.

Public health relevance
Healthcare providers must balance the cardiovascular benefits of blood pressure lowering medication with the potential risk for falls among older adults with hypertension. Blood pressure has traditionally been measured in the clinic setting; however, for many people, blood pressure differs when measured inside versus outside of the clinic setting. The proposed study will determine whether self-measured blood pressure by a person in their home, a procedure called home blood pressure monitoring, is useful for identifying older adults taking antihypertensive medication who are at increased risk for falls.